Biobank phenotyping tools for improved understanding and management of eye diseases and disparities

PROJECT SUMMARY
One of the areas of emphasis on the National Eye Institute's (NEI) strategic plan is to bridge the gap between
genomics and mechanisms of disease. Vast clinically relevant information on diseases, demographics,
exposures, and traits is captured in electronic health records (EHRs). This phenome data can be overlayed on
biospecimen-derived data (such as genetic variants) and interrogated to uncover and clarify disease
associations. These associations can in turn help us infer mechanisms of disease, contextualize clinical
observations, develop risk prediction models for clinical management, and identify new research directions.
Phecodes quickly capture a coded representation of the entire phenome in EHRs without accessing identifiable
information, thus allowing an unrestricted exploration of any disease or phenotype as a potential cause or
consequence of all others. Phecodes were last revised in 2013, when we published a replication study of known
genetic associations from published GWAS. The current version of our phecodes (v1.2) has proven useful for
numerous research applications and, as such, has been incorporated into novel phenome-based research
pipelines to accelerate the study of both rare and complex diseases. However, our preliminary work shows that
phecode v1.2's hierarchical structure lacks the resolution required to accurately identify many sigh-threatening
conditions. This limits the scope of eye-related knowledge that can be gleaned from phenome-dependent
association studies using biobanks. Our goal is to support new and evolving use-cases for phecodes to study
eye-related diseases and health disparities in diverse biobanks. To fill this gap, we recently created a new
version of phecodes (PheX) with enhanced granularity to resolve and capture many more clinical diagnoses than
v1.2. We propose to: (1) Compare the resolution and reliability of PheX (vs. v1.2) to capture common and rare
eye phenotypes; (2) Develop linkages between eye related-PheXs and numerous controlled vocabularies and
ontologies for research; (3) Test the scalability of PheX in external biobanks through replication of eye disease
GWAS results to enhance generalizability of association studies to diverse populations; (4) Incorporate PheX
into novel phecode-based research pipelines; (5) Use PheX for PheWAS to study comorbid associations and to
develop a catalog of morbidity and comorbidity maps with a focus on population disparities; (6) Incorporate post-
coordination methods for phecode terms to enhance phenome capture; and (7) Share the new eye-specific PheX
(iPheX) along with quality assessment methods in easily accessible and deployable packages to facilitate
ophthalmic research in diverse biobanks. This project meets several strategic goals of the NIH and NEI,
including: (1) enriching our awareness of ocular epidemiology in groups under-represented in vision science and
identifying risk factors for ocular disease in underserved populations (we will use All of Us, a biobank with
intentional population diversity); (2) using science to integrate cross-modality data to understand diseases
(genomics, phenomics); and (3) understanding how genomic variants affect disease.

Public health relevance
NARRATIVE Lack of representation of racial and ethnic minorities in genetic repositories, association studies, and prediction models results in their unequal benefit from medical and technological advancements, thus contributing to the persistence of health disparities. We will develop accessible methods to explore and meta-analyze data from diverse biobanks through a common coded language called phecodes and optimize phecode resolution for eye disease phenotypes (eye phecodes) with the hopes of reducing ocular health disparities. We will share these tools to allow others to practically leverage biobank data to explore ophthalmic disease patterns, associations, and disparities with results that are reliable, reproducible, and generalizable.